Genetic Analysis of Neuronal Hypoxia Resistance

PROJECT SUMMARY
Hypoxia (O2 deprivation) plays a central role in diverse human diseases, including ischemic stroke, myocardial
infarction, pulmonary hypertension, Cerebral Palsy, COVID-19, and cancer. Metazoans respond to hypoxia by
employing the conserved hypoxia response pathway. The pathway senses O2 through a prolyl hydroxylase
(PHD) enzyme, which negatively regulates the transcription factor Hypoxia Inducible Factor α (HIFα). When
hypoxia ensues, PHD enzymes lack O2 to hydroxylate HIFα, resulting in HIFα stabilization and the
transcriptional regulation of multiple target genes that help the organism survive. While the HIFα pathway has
been well studied in tissue culture, a full understanding of how it operates in specific tissues (particularly
neurons) in vivo to provide tailored responses is needed. This proposal takes advantage of genetics and an
intact, isogenic model organism (C. elegans) that can thrive under hypoxia, and whose environment and
genetics can be controlled with fidelity and reproducibility. The overall premise of this proposal is that the
hypoxia response pathway pathway protects against hypoxic damage by (1) removing mitochondria through
mitophagy, which eliminates a source of oxidative stress, and by (2) mobilizing antioxidant metabolism, which
detoxifies free radicals during hypoxia and reoxygenation.
We hypothesize that HIF-1 promotes this metabolic reprograming by binding an enhancer sequence
and activating the expression of the PEP carboxykinase pck-1, a key enzyme for moving metabolites through
gluconeogenesis. Aim 1 tests this hypothesis by using CRISPR/Cas9 editing to remove this enhancer, then
testing for the effects on HIF-1 binding, pck-1 and global gene expression, metabolism, oxidative stress
resistance, neurodegeneration, and hypoxia survival.
Preliminary cell biological approaches with a genetically encoded fluorescent reporter for mitophagy
suggest that HIF-1 promotes mitophagy. We hypothesize that HIF-1 promotes mitophagy by binding
enhancer sequences and activating the expression of the mitophagy receptors fndc-1 and dct-1. Aim 2 tests
this hypothesis by using CRISPR/Cas9 editing to remove these enhancers, then testing for the effects on HIF-
1 binding, global gene expression, mitophagy and bulk autophagy, metabolism, oxidative stress resistance,
neurodegeneration, and hypoxia survival.
Recently, our media sterilizer and automated Petri dish pourer reached the end of its life. This large
equipment failure is inhibiting our progress towards both aims, as this fundamental equipment is essential for
every experiment we conduct. An administrative supplement is requested to replace this equipment and
restore our progress towards understanding how the hypoxia response pathway operates. A better
understanding of the pathway will provide therapeutic targets for diseases associated with hypoxia.

Public health relevance
RELEVANCE Hypoxia (O2 deprivation) plays a central role in a diverse array of human diseases, including ischemic stroke, heart attack, COVID-19, and cancer, yet we have a poor understanding of how our tissues respond and combat against hypoxic damage. It is critical to identify and functionally characterize key targets of this response in order to develop novel applications for the treatment and prevention of disorders and diseases that involve hypoxia as part of their etiology. This administrative supplement seeks funds to replace broken equipment needed for the production of biological media used in experiments to address hypoxic stress.